Pregnancy Changes in Vitamin D Metabolism, Maternal Obesity and the Association with Offspring Bone: A Secondary Analysis of Two US Cohorts

PROJECT SUMMARY/ABSTRACT
Maternal vitamin D status during pregnancy will have significant implications for offspring bone health. In order to
optimize peak bone mass and deter the development of osteoporosis, a life course approach is needed which begins with
improving maternal vitamin D status during pregnancy. Total 25-hydroxyvitamin D (25(OH)D) is commonly used as a
biomarker of vitamin D status as it reflects vitamin D exposure. Studies suggest 40-45% of US women have insufficient
25(OH)D concentrations in pregnancy with higher risks among women with obesity. Despite the potential benefits of
improving maternal vitamin D status on offspring bone, pregnancy-specific vitamin D guidance does not exist. This has
been partly hampered by our incomplete understanding of vitamin D metabolism during pregnancy. Further, high-risk
subgroups such as women which begin pregnancy with obesity have been largely understudied in prior work. To better
understand the physiological changes in vitamin D metabolism which occur during pregnancy, we propose to characterize
multiple vitamin D metabolites and their ratios [termed the “vitamin D metabolome”] in two parallel cohorts of US
women collected longitudinally across pregnancy, from early to late phases. In specific aim 1, we will assess the
longitudinal changes of total 25(OH)D, 1,25 dihydroxy vitamin D (1,25(OH)2D), the catabolic products: 24,25-
dihydroxyvitamin D (24,25(OH)2D), 1,24,25-trihydroxyvitamin D (1,24,25(OH)3D), and 25-hydroxyvitamin D-26,23-
lactone (25(OH)D3-26,23-lactone) and their ratios (i.e., 25(OH)D: 24,25(OH)2D, an indicator of CYP24A1 activity),
across pregnancy and by maternal pre-pregnancy obesity status. Then in specific aim 2, we will determine the cumulative
effect of maternal circulating 25(OH)D level across pregnancy on offspring bone outcomes while considering maternal
obesity. This will enable the identification of circulating 25(OH)D thresholds in pregnancy which are associated with
optimal offspring bone outcomes and can be used in subsequent clinical trials. This is a secondary analysis in which we
will pool participants from two prospective cohorts of pregnant women from the central Arkansas area and with sera
available from two or more pregnancy timepoints (12-, 24-, or 36-weeks’ gestation). We will utilize a novel multiplex
liquid chromatography tandem mass spectrometry for the assessment of multiple vitamin D metabolites. In addition to
offspring bone mass in early childhood, we will use bone turnover markers as a potential adjunctive health outcome of
offspring skeletal development. Hence, this proposed research has the potential to significantly contribute towards
improving our understanding of the pregnancy-related changes in vitamin D metabolism and also fill gaps regarding these
changes among obesity-affected pregnancies. This may lead to identification of novel clinical biomarkers for the
assessment of vitamin D during pregnancy. Further, it will identify pregnancy-specific targets for current vitamin D
assessment methods and critical time periods for intervention which will directly inform subsequent clinical trials among
high-risk subgroups of the US population. Our collaborative research team is well-positioned to do this work with
complementary expertise in clinical biochemistry, micronutrient requirements, maternal and child nutrition and
development, vitamin D metabolomics, and biostatistics.

Public health relevance
PROJECT NARRATIVE This study will fill gaps in our understanding of the pregnancy-related changes in vitamin D metabolism, including among obesity-affected pregnancies, which can help in the identification of novel clinical biomarkers for the assessment of vitamin D during pregnancy. It will also identify pregnancy-specific targets for vitamin D assessment methods and critical time periods for intervention to be used in subsequent clinical trials. This is necessary to inform on the amount of vitamin D necessary for US pregnant women to optimize both maternal and offspring health.